AD HOC CONSULTING AND OPINIONS FOR REGULATORY RELATED SERVICES FOR CONTRACEPTIVE RESEARCH

The Contraception Research Branch has several grant awards and contracts that focus on the development of new contraceptives for men and women – each project has a regulatory requirement. There is a clear benefit to increasing Program’s understanding of these requirements for identified applications and funded awards. There is also a benefit to increasing the field’s knowledge on this topic overall.
This contract is to support the service on regulatory requirements in providing critical insight into commenting, designing, packaging, and submitting applications to regulatory bodies which can inform Program in making scientific decisions to meet the government’s goal: new contraceptive options for men and women. Seraphim Life Sciences Consulting has several years’ experience providing opinions for regulatory requirements on developing technologies (e.g., drugs and devices), including contraceptives.